Leveraging symbiosis and desert biogeography for discovery of host-selected natural products

PROJECT SUMMARY/ABSTRACT:
Ecologically-guided approaches have helped to reinvigorate natural products chemistry discovery efforts in
recent years. Such approaches take advantage of ecological relationships in which chemical defenses produced
by microbial symbionts benefit a host animal. These ecological relationships have recently been appreciated to
be ubiquitous and sampling of these systems has an impressive track record of delivering novel, active
compounds. However, generalized approaches for efficiently accessing novel chemical scaffolds and analogs of
promising compounds have not been developed. As such, the potential for chemical discovery from such
systems remains unrealized.
The proposed project develops a host-associated biogeography framework for chemical discovery by tapping
into a completely unexplored ecological niche with outstanding discovery potential: bacterial symbionts of
Trachymyrmex ants in the American Southwest. In addition to uncovering novel antibiotic compounds, this work
will quantify chemical diversity across this niche and determine geographic, environmental, and biological factors
that predict the presence of active novel compounds. In Aim 1, a diverse library of 150 natural product extracts
will be assembled from cultures of symbiotic bacteria isolated from southwestern Trachymyrmex ants. These
ants will be systematically sampled from sites across the American Southwest such that the library captures
diversity across multiple biogeography variables: location, host ant species, and habitat. Aim 2 will establish how
these biogeography variables predict the distribution of antibiotic activity and chemical diversity across this
library. Antibiotic activity screening against both ecologically-relevant and clinically-relevant microbial pathogens
will establish correspondence between ecological and clinical activity. Metabolomics analysis of this library will
reveal how molecules are distributed as a function of biogeography variables. Aim 3 of this proposal will deliver
on ecologically-guided discovery from this unexplored niche by characterizing highly active novel compounds
from this library, with a particular focus on synergistic antibiotics. Through activity-guided fractionation and
detailed chemical characterization, this aim will yield 2-4 novel bioactive compounds. This proposal will lay the
groundwork for further chemical discovery from this and other ecological niches.
Undergraduate researchers will be engaged in all components of this work through modular summer and
senior thesis research projects as well as a course-based research experience. This project will broaden
participation in science research at the Claremont Colleges by women and other groups underrepresented in
science. Additionally, the project will strengthen the research environment of multiple institutions at the
Claremont Colleges through enhanced research opportunities on significant research, through a variety of new
collaborations, as well as through bringing modern instrumentation to the Keck Science Department.

Public health relevance
PROJECT NARRATIVE: Chemical discovery from nature, including from symbiotic microbes, represents a productive strategy for delivering new antibiotics and other drugs. This proposal seeks to discover active molecules with clinical potential from a niche with high discovery potential, desert Trachymyrmex ants, and to determine how such molecules are distributed across this niche. These findings will provide a framework for efficiently accessing new drug leads from this and related systems.